Tumor selective inhibition of the WNT pathway

PROJECT SUMMARY
WNT pathway hyperactivation is a dominant oncogenic driver in colorectal cancer (CRC), and directly linked to
disease progression and drug resistance in many other cancer types, including lung (LUAD), breast and prostate
cancer. Indeed, there is strong evidence from pre-clinical model systems that targeting hyperactive WNT
signaling can provide significant therapeutic benefit in multiple cancer models. We and others have shown that
blocking the function of redundant Tankyrase enzymes (TNKS and TNKS2) can suppress hyperactive WNT
signaling, impede cancer cell proliferation and drive differentiation, particularly in CRC. However, WNT signaling
is also critical for the homeostatic maintenance of multiple organ systems. Consequently, drugs that effectively
block WNT, like TNKS inhibitors, have shown a range of on-target toxicities in essential tissues such as the
intestine and bone. Defining a strategy for tumor-restricted WNT pathway suppression is a major goal in precision
oncology.
Advanced cancers often contain significant disruptions to their genomes, including gains and losses of large
chromosome segments. These large-scale alterations encompassing many genes are presumed to support
cancer cell growth. However, they also lead to loss of ‘passenger’ genes that do not drive cancer progression,
but may unintentionally ‘rewire’ the signaling networks. Such cancer-specific collateral damage may provide
opportunities for therapeutic intervention. We will test the hypothesis that a large chromosomal deletion on
chromosome 8p, which induce loss of TNKS, create a tumor-specific dependency on TNKS2 that can be
exploited to block WNT only in cancer cells. Because normal cells express both redundant family members, they
should remain unaffected by selective targeting. In Aim 1, using a panel of CRC, LUAD and breast cancer cell
lines and patient-derived organoids, in combination with CRISPR-based genome editing, we will determine how
heterozygous and homozygous chromosome deletions impact the response to TNKS2 inhibition. Further, we will
define downstream protein targets that are most sensitive to TNKS disruption and TNKS2 suppression. In Aim
2 we will exploit a unique transgenic shRNA system we developed, to define the safety of systemic and selective
TNKS2 inhibition in vivo and determine the efficacy of selective TNKS2 inhibition in immunocompetent animal
models of aggressive CRC and LUAD. Aim 3 will determine the efficacy of novel TNKS2-selective small
molecules in cancer cell lines and organoid models and evaluate potential mechanisms of therapy resistance to
TNKS2 inhibition.
Identifying a safe and effective approach to block hyperactive WNT signaling in multiple tumor types could have
a profound impact on the clinical management of advanced cancers. Thus, we believe our work will contribute
substantially to the overall goal of developing safe and effective targeted therapies for WNT-driven cancers.

Public health relevance
PROJECT NARRATIVE Many cancers are driven by increased activation of a signaling pathway called WNT. Drugs that block WNT often cause damage to normal organs and have so far been difficult to use in a clinical setting. Here, we will test a new approach that aims to exploits genetic changes in cancer cells and allow cancer-specific suppression of WNT treatment of colorectal cancer.